Purpose in life: Mechanisms to support healthier cognitive aging and reduce risk of Alzheimer's disease

Project Summary
Purpose in life is the belief that one’s life and activities are goal-oriented, directed, and worthwhile. This belief is
associated consistently with better outcomes, including greater engagement in health promoting behavior (e.g.,
less smoking, more physical activity), fewer chronic diseases (e.g., cardiovascular disease, diabetes), and
ultimately greater longevity. Independent of behavioral and clinical factors, purpose in life is associated with
better cognitive outcomes, including lower risk of Alzheimer’s disease and related dementias (ADRD). ADRD
remains a significant challenge to patients, their families, and the healthcare system, as it is one of the leading
causes of death that lacks disease-modifying treatments or cures. There is a growing literature that shows that
purpose in life is protective across the arc of the ADRD disease spectrum: It is associated with better
performance on cognitive tasks and less cognitive decline prior to dementia onset, it is protective against
cognitive impairments, both mild and severe, and, even after diagnosis, it is associated with fewer behavioral
and psychological symptoms of dementia. In a parallel literature, there is consistent evidence from randomized
controlled trials that purpose in life is malleable and can be increased through intervention. Purpose in life is thus
poised to be a powerful target of intervention to improve cognitive outcomes, from maintaining cognitive function
in middle adulthood to improving outcomes in dementia care. The next step in intervention development is to
identify the putative mechanisms of action hypothesized to change in response to the intervention and explain
the relation between purpose and better cognitive outcomes. Once these mechanisms are identified,
interventions that increase purpose to improve cognitive outcomes can be developed and tested. As a step
toward this long-term goal, the present study will use ecological momentary assessments (EMA) to identify the
daily mechanisms responsible for the association between purpose in life and healthier cognitive outcomes. In
particular, we will test the hypothesis that purpose in life is associated with greater momentary engagement and
better momentary cognition, which will support healthier cognitive function over time. We will address these
associations in three groups considered critical populations for intervention: older adults with subjective cognitive
impairment, older adults with healthy cognition, and middle-aged adults. This research will provide much needed
information on putative mechanisms of action that explain how purpose protects cognition. Such information is
critical to develop purpose interventions that promote healthier cognitive aging.

Public health relevance
Project Narrative Alzheimer’s disease and related dementias continue to be a critical public health issue because they are prevalent and have significant emotional, relational, and financial costs. Purpose in life is a psychological resource that buffers against ADRD at every stage of the disease and may be a powerful target of intervention because it is malleable and its positive correlates wide-reaching. It is now necessary to identify the putative mechanisms of action that explain how purpose leads too healthier cognitive outcomes to develop effective interventions for healthier cognitive outcomes.